Structure/Function of Potential Human Cytochrome P450 Drug Targets

PROJECT SUMMARY
Our laboratory focuses on the structure and function of human membrane cytochrome P450
enzymes using a set of integrated structural and biochemical techniques. These monooxygenases play
important roles in either the metabolism of drugs or as drug targets for prevalent diseases such as
cancers, diabetes, and cardiovascular conditions, as well as rare diseases such as neuromuscular
spastic paraplegia and Bietti's Crystalline Dystrophy. Many drug-metabolizing and steroidogenic P450s
have been well characterized functionally and structurally by our lab, supporting improved drug design,
but many other P450 drug targets are very poorly characterized. In some diseases inappropriate P450
action is implicated and inhibitors are likely to be an advantageous treatment, but the active site
knowledge to design them is unknown until we determine structures. In other cases P450 mutations
cause a disease, but not knowing whether the defect is in protein stability or some aspect of catalytic
function similarly impedes effective progress toward developing effective therapeutics. We have a 20-
year track record defining P450 interactions with ligands for various drug-metabolizing and
steroidogenic human enzymes. For most we generated the first structures by X-ray crystallography.
The overall goal of the proposed research for the next five years is to generate initial X-ray
structures and corresponding biochemical information of a selected set of validated disease-related
P450 enzymes to enable viable pursuit of drug design A subset of poorly-characterized human P450
enzymes with significant evidence supporting their roles in one or more disease states were identified
and will be pursued using an overall strategy including recombinant expression and purification,
identification of new ligands as necessary, evaluation of clinical mutations when appropriate, followed
by integrated determination of substrate and inhibitor binding affinities, substrate metabolism, inhibitor
efficacy, and active site topology, primarily by X-ray crystallography and/or pharmacophore generation.
These P450/ligand interaction studies, along with proposed studies of P450 interactions with their
catalytic partner proteins and membranes, are expected to provide critical foundational knowledge
facilitating broad impacts across a number of major and rare diseases. The feasibility of this work rests
not only on the strong premise for the selected P450 enzymes, but the investigator track record,
laboratory expertise, and access to all of the required instrumentation and resources in an exceedingly
strong research environment. With this combination of resources we have previously accomplished
similar feats for a number of other human membrane P450 enzymes. Our overall vision is to creatively
employ multiple techniques to answer some of the most critical questions about how this diverse
enzyme superfamily functions and can be modulated to improve human health.

Public health relevance
PROJECT NARRATIVE Human cytochrome P450 enzymes both break down drugs and other foreign chemicals and serve important functions in key physiological pathways. The proposed research will define the functional and structural characteristics of multiple P450 enzymes to 1) understand how defects in some of them cause disease, 2) to identify specific active features that enable selective inhibition to treat other diseases, and 3) understand their interactions with other proteins/lipids. The outcomes of this research should provide starting points for addressing multiple human diseases ranging from ranging from highly prevalent ones like cancers, diabetes, and cardiovascular diseases to rare diseases like spastic paraplegias.